Center for Biomedical Engineering Technology Acceleration (BETA Center)

The BETA Center is being developed as a trans-NIH resource to aid other IRP researchers in connecting with engineering practices and resources to apply to their own research. To kickoff this new center, we held two listening sessions with potentially key stakeholders from multiple ICs to provide feedback on what they would find useful from such an engineering resource. Progress has been made towards each of these endeavors and the BETA Center community of investigators is growing.

1.Research Collaboration Facilitation
1:1 research collaboration connections to innovate solutions

2. Core Lab Services
IDEAS, BEPS, AIM
Molecular Tracer Imaging Center
Systems and computational biology expertise and consultation

3. MakerSpace
3-D printers, Metal 3D printer, machine shop, microfabrication, computer aided design (CAD).

4. Trainee and Recruitment Programs
Recruiting nationally for BESIP, Undergrad internships, Postbac IRTA, Postdoc positions,
Recruitment and professional development initiatives
IRP Bioengineering community building

Summer undergraduates: Biomedical Engineering Summer Internship Program (BESIP) and BETA Center
Summer Internship Program
BESIP program hosted 16 summer interns for 2023
New pilot program this year: 6 BETA Center Summer Interns hired this year with first time
researchers and mostly from minority-serving institutions. They were mentored in labs across
three different ICs:
Future plans for BETA Center to fund 4 NIH OITE-PEP scholars FY24 in arrangement with OITE